Enhancing K-12 School Safety During a Respiratory Viral Pandemic

PROJECT SUMMARY/ABSTRACT
While progress has been made since the onset of the COVID-19 pandemic, the spread of the virus still poses a
threat to school safety. There is a significant concern regarding viral transmission in K-12 schools as a result of
close social interactions between children, crowded institutional environments, high risk extracurricular activities,
and insufficient vaccination coverage. Children have close interactions with parents and other household
members who are active in all sectors of society. Keeping K-12 schools safe is crucial to minimizing community
transmission and restoring optimal societal functions.
COVID-19 is unlikely to become extinct due to the emergence of new variants, rapidly waning antibodies, COVID
behavioral fatigue, and low vaccination coverage. The challenges of prevention and control in K-12 schools
persist, from both the current pandemic and future respiratory threats. Our study anticipates next steps of
outbreak prevention and management, and the topics of study (i.e. vaccinations) are highly relevant to school
safety in this or future respiratory threats (COVID, influenza). We will examine the experience of K-12 schools
during the pandemic through the following aims:
Aim 1: Conduct a scoping review to identify and inventory the current research and evidence quality on the
impact of COVID-19 on K-12 schools
Aim 2: Investigate individual stakeholder- and school administrative-level experience and concerns regarding
vaccination and safety practices during the pandemic through research in local K-12 schools via stakeholder
longitudinal surveys (Aim 2A) and qualitative exploratory semi-structured interviews of school administrators
(Aim 2B).
Aim 3: Assess the implementation of a Hardware-Assisted Bluetooth-based Infection Tracking Device (HABIT)
in a high school setting through a mixed-method study. We will assess HABIT's implementation outcomes (ease
of use, interface, and satisfaction, acceptability, usefulness, coherence, setting, adherence, appropriateness) in
a K-12 school using qualitative focus group interviews with key stakeholders, survey responses, and HABIT
device usage data. We will present both the quantitative performance metrics and the qualitative contextualized
insights of HABIT implementation.
The proposal is the research component of a comprehensive training plan that is designed to provide a
foundation for my career as a physician-scientist through the Yale MD-PhD program. Through these aims, we
seek to provide insights that are essential for developing an integrated approach to keep both children and
teachers safe in the event of the current and future respiratory viral outbreaks and pandemics.

Public health relevance
PROJECT NARRATIVE The COVID-19 pandemic has painfully demonstrated that K-12 school safety during a respiratory viral pandemic has a crucial role in community viral transmission control, children’s and teachers’ welfare, and optimal social functioning. With the overall objective of understanding K-12 school experience and safety strategies during the pandemic, we aim to identify and review the current research on the topic by performing a scoping review (Aim 1); to examine school stakeholder (individuals-level) and school administrative (institutional-level) perceptions, concerns, and experience through stakeholder longitudinal surveys (Aim 2A) and administrator interviews (Aim 2B); to examine the implementation outcomes of an institutional-level Bluetooth Digital Contact Tracing intervention through questionnaires and focus group interviews (Aim 3). With COVID-19 unlikely to vanish, and schools constantly threatened by respiratory viruses, the proposed study offers holistic insights into how to effectively keep schools safe during the current and future pandemics.